Domestication and characterization of TM7-the most elusive oral phylum

Abstract
Saccharibacteria (also known as TM7) are ubiquitous members of the human oral microbiome whose relative
abundance increases dramatically during mucosal inflammation (gingivitis and periodontitis), yet their biology
and role in microbial ecology and pathogenesis have remained largely elusive. During the previous funding
cycles, we successfully isolated TM7x, the first member of the uncultivated TM7 phylum from humans. we
demonstrated that TM7x has ultrasmall cell size with a highly reduced genome, and it displays an obligate
episymbiotic lifestyle where TM7x lives on the surface of its bacterial host Schaalia odontolytica XH001. Our
studies have provided critical insights into the unique biology of these ultrasmall bacteria and their impact on
the physiology and pathogenesis of host bacteria. The knowledge gained in our prior work not only allows a
better understanding of the TM7 phylum, but also sheds light on the general biology of Candidate Phyla
Radiation (CPR) organisms among which episymbiosis is predicted to be a preferred lifestyle. Nevertheless,
due to the lack of effective genetic tools, the genetic determinants that govern TM7x and XH001 interaction
and the molecular underpinnings of episymbiosis remain largely unexplored.
In this ongoing project, we have found that TM7x/XH001 episymbiosis is a dynamic, reciprocal, multi-stage
process that spans four main phases: initial binding, host killing, recovery and stable symbiosis. These
biological processes are highly relevant to their prevalence and persistence in the human oral cavity. Our
analyses suggest the presence of two forms of type IV pili (T4P) in TM7x which may carry out diverse
functions. Specifically, in the initial binding phase, the recognition and binding, a critical step in establishing
episymbiosis, is mediated through TM7x-encoded T4P and can be inhibited by exogenously added sugars,
similar to a key cell surface carbohydrate component in the host bacterium XH001. Importantly, a recent
significant breakthrough in TM7x genetics now enables significant advancements. Thus
, the overall goal of the
proposed study is to build upon intriguing new findings within the distinct phases during episymbiosis and
leverage newly developed molecular tools to achieve a mechanistic level understanding of the detailed
molecular processes required for bacterial episymbiosis in the human microbiome.
The proposal comprises two parts. Part I is designed for focused investigation on the critical roles of multiple
TM7x-encoded T4P in its symbiotic lifestyle; while Part II seeks to identify and validate the key molecular
components in TM7x and its host governing the dynamic symbiotic process.
The successful completion of
these aims will provide a fundamental mechanistic understanding of the episymbiotic interaction between TM7
and their hosts, setting a solid foundation with key enabling toolsets and molecular level information to
ultimately understand their observed in vivo persistence in disease, impact on the pathogenesis of oral bacteria
and potential to modulate the microbial ecology within the human microbiome.

Public health relevance
Projective Narrative There are many ultra-small bacteria in our body, including in the mouth, that cannot live by themselves, but rather require intimate physical association with other bacteria to grow, which makes it difficult to study them in the laboratory. Our research is focused on studying, at the molecular level, the first ultra-small bacterium that has been successfully isolated from the oral cavity and grown in our laboratory. Once we understand how it interacts with its partner and affects other oral bacteria, it will help to investigate their role in our health and disease.